Src Inhibition Induces Selective Autophagic Killing of T. gondii Independently of EGF Receptor

PROJECT SUMMARY
Toxoplasma gondii is an obligate intracellular parasite and causative infectious agent of ocular toxoplasmosis
(OT). This chronic, recurrent infection is the top cause of infectious retinitis worldwide and can lead to
blindness in one eye in 25% of patients. Current treatment does not positively influence visual outcomes. T.
gondii resides in a parasitophorous vacuole and induces mechanisms that block autophagosome-lysosome
formation from targeting the parasite in infected cells. After parasite invasion, T. gondii activates the host cell
signaling molecule, Src, which drives prolonged autophosphorylation of the EGFR and activates the
downstream autophagy inhibitor, Akt. Activated Akt persistently avoids autophagic targeting and survival within
the cell. Previously, EGFR inhibition was shown to induce autophagic killing of T. gondii in approximately half of
the cells and is partially protective against OT. This partial protection may be a result of partial Akt inhibition
and the restricted expression of EGFR. Thus, Src is likely a better target because it appears to activate Akt
independently of EGFR and is broadly and highly expressed in neural tissue and the retina. This project seeks
to understand the host signaling mechanism utilized by T. gondii in cells lacking EGFR that prevent
autophagy-mediated targeting of the parasite, to understand the molecular events triggered by Src inhibition
that are responsible for selective targeting of T. gondii by autophagy, and to determine whether Src inhibition
protects against OT. Our preliminary studies demonstrate that knockdown of Src induces parasite killing in cells
lacking EGFR through an autophagy-mediated mechanism. Additionally, Src inhibition induces autophagic
targeting that appears dependent on the activation of a protein kinase. Therefore, the central hypothesis of this
proposal is that, even in the absence of EGFR, Src inhibition kills T. gondii due to protein kinase-dependent
selective targeting by autophagosomes, and Src inhibition controls OT. Experiments proposed in Aim 1 will
investigate the role of Src in preventing the autophagic killing of T. gondii in the absence of EGFR in vitro.
Experiments proposed in Aim 2 will explore the role of protein kinase activation in selective parasite targeting
by autophagosomes after Src inhibition. Aim 3 will explore the effects of Src inhibition on pre-established OT in
vivo. Together these data will define mechanisms in which T. gondii inhibits autophagic targeting, explain how
autophagy selectively targets the parasite and may be applied to improved treatment for OT.

Public health relevance
PROJECT NARRATIVE Toxoplasma gondii is the leading cause of infectious retinitis worldwide and is a neglected parasitic infection in the United States with over 11% of the population testing seropositive. Recent work conducted by the Subauste lab has demonstrated that T. gondii can manipulate host cell signaling to prevent degradation by the autophagolysosome, thus preventing this signaling can result in therapeutic implications by promoting autophagic eradication of the parasite. The mechanism for autophagosome formation during T. gondii infection has yet to be elucidated and will identify a possible novel mechanism of selective autophagy.